Microbiome-induced intestinal Th17 cells and microbiome independent gamma delta T cells improve fracture healing

PROJECT SUMMARY
Fractures are a common traumatic injury in humans. Fracture healing is often complicated by delayed unions
and non-unions, creating a need for innovative strategies for fracture healing. We reported that the intestinal
microbiome and gut permeability are potent factors governing the efficiency of fracture repair. We found that
microbiome depletion by antibiotic treatment impairs fracture healing in mice. We also found that optimal fracture
repair occurs in the presence of segmented filamentous bacteria (SFB) in the gut microbiome. SFB are gut
commensal bacteria that are potent inducers of Th17 cell generation – a population of IL-17 producing CD4+
cells. Based on published and preliminary data, we hypothesize that early after a fracture, cytokines released by
γδ T cells and other inflammatory cells within the fracture site increase local and circulating levels of inflammatory
cytokines. Circulating cytokines induce a leaky gut phenotype, which, together with a microbiota containing SFB,
results in the heightened expansion of intestinal Th17 cells. Attracted by chemokine gradients induced by callus
inflammation, intestinal Th17 cells migrate to the to the fracture callus, where they further increase local IL-17
levels. The combined production of IL-17 by γδ T cells and Th17 cells originating from the gut shortens and
optimizes fracture repair. Attesting to the relevance of γδ T cells and Th17 cells for fracture repair, mice lacking
γδ T cells or mice with a paucity of Th17 cells exhibit suboptimal fracture healing. Given the importance of specific
bacterial taxa for the expansion of intestinal Th17 cells, and thus for fracture repair, we further hypothesize that
induction of Th17 cells by specific live microbial biotherapeutics may improve fracture healing. Because the
specific phenotype of the γδ T cells that function in fracture healing is unknown, that the relative contribution of
Th17 cells to fracture repair is unknown, and if fracture healing is expedited by IL-17A or IL-17F is unknown, in
Aim 1 we will identify the subsets of γδ T cells relevant for fracture healing, investigate the contribution of Th17
cells to fracture repair, and to determine the relevance of IL-17A and IL-17F for fracture repair. In Aim 2, we will
determine the contribution of increased gut permeability to fracture repair and comprehensively characterize the
mechanisms involved. This will be achieved by preventing or enhancing the increased in gut permeability
induced by fractures using pharmacological agents. In Aim 3 we will determine if precision probiotic treatment
using sequential supplementation with bacteria known to expand intestinal Th17 cells in humans followed by an
anti-inflammatory probiotic will expedite and/or improve fracture healing. The phenotypic characterization of T
cells implicated in fracture repair, the definition of mechanisms whereby fractures increase gut permeability, and
an assessment of the effects of precision probiotic treatment will yield essential data to inform novel strategies
for optimizing fracture healing.

Public health relevance
PROJECT NARRATIVE This project will determine the contribution of gut permeability, γδ T cells and Th17 cell inducing bacteria to fracture repair. Our study will provide evidence that elements of the gut microbiome facilitate fracture repair by optimizing the inflammatory phase of the fracture callus formation. The project is important because sequencing of the stool microbiome may be used to predict subjects likely to have a more efficient fracture repair process.